University of Virginia Cancer Center Support Grant

OVERALL – PROJECT SUMMARY/ABSTRACT The University of Virginia Cancer Center (UVACC) is a matrix cancer center that brings together 162 Members from 25 Departments in the Schools of Medicine, Nursing, and Engineering, and in the College of Arts and Sciences. The UVACC receives $12.06M direct costs from NCI, $19.40M from other peer-reviewed sources, and $7.44M from non- peer-reviewed sources, for a total of $38.91M in overall direct cost funding. The members are highly productive and collaborative, having published 1,016 Program-selected publications, of which 27% are intra-programmatic, 11% are inter-programmatic, and 45% are collaborative with other NCI Cancer Centers. Of these publications, 26% have an impact factor of 10 or greater. Through faculty recruitment and robust infrastructure development, the UVACC has continued to build on its exceptional basic science foundations. Since the last renewal, UVACC has greatly enhanced its ability to accelerate clinical and translational cancer focused research and has built a robust population science program.
Sixty nine new Members have joined the UVACC, including twenty four basic
scientists, ten translational researchers, nineteen clinical investigators and sixteen population scientists. The UVACC has four Programs: Cancer Biology (CBIO), Molecular Genetics and Epigenetics (GEN), Cancer Therapeutics (CRX), and Cancer Control and Population Health (CPH). This application requests support for seven Shared Resources: Advanced Microscopy Facility (AMF), Biomolecular Analysis Facility (BAF), Biostatistics Shared Resource (BSR), Biorepository and Tissue Research Facility (BTRF), Flow Cytometry Core (FCC), Molecular and Immunological Translational Sciences Core (MITS), and Population Health and Cancer Outcomes Core (PHCOC). In addition, we request support for UVACC Senior Leadership, an Administration Core, Planning and Evaluation, Developmental Funds, a Cancer Research Career Enhancement Core (CRCE), Community Outreach and Engagement (COE), Clinical Protocol and Data Management (CPDM), and a Protocol Review and Monitoring System (PRMS).
The mission of the UVACC is to reduce the burden of cancer for the patients of today, through skilled, integrated, and compassionate care and to eliminate the threat of cancer for the patients of tomorrow, through research and education. Because it is a matrix cancer center that is fully integrated within a leading public university, the UVACC has a special opportunity and responsibility to bring a universe of new knowledge and technology into cancer research and care for the people in its catchment area. The UVACC is requesting Cancer Center Support Grant (CCSG) funding and designation as an NCI-designated Comprehensive Cancer Center.

Public health relevance
OVERALL – PROJECT NARRATIVE The mission of the University of Virginia Cancer Center (UVACC) is to eliminate the threat of cancer, with skilled, compassionate care for the patients of today and with research and education for the patients of the future in an environment that promotes diversity, equity, and inclusion. UVACC Members draw on the deep resources of the University of Virginia to identify, analyze, and validate some of the most significant targets for cancer therapy, diagnosis and prevention, and to speed their translation to clinical application for the benefit of the people of the catchment area and beyond.